Mechanisms of Functional Axon Regeneration

A fundamental question in neurobiology is how axons respond to injury and disease. Damaged neurons can
sometimes repair themselves by a process called axon regeneration. However, many neurons do not
regenerate, often resulting in permanent deficits following nerve injury. Clinical strategies to repair the injured
nervous system are lacking because the mechanisms that determine whether an injured axon will functionally
regenerate are poorly understood. Therefore, determining the mechanisms that regulate individual components
of the regeneration response, including those that determine whether an injured axon will regenerate and
whether it will reform functional synapses (functional axon regeneration), is critical to understanding how to
improve functional recovery after injury. To reach this goal we are investigating how a number of genes that we
recently identified as regulators of functional axon regeneration determine whether an injured axon will we
repaired. Our approach is to take advantage of the powerful C. elegans model of axon regeneration, which has
a highly conserved genome, is genetically tractable, and in which functional axon regeneration can be studied
in vivo and with single axon resolution, to perform detailed genetic analyses, laser axotomy, imaging, and
behavioral assays. Answering the above questions is essential to our understanding of functional axon
regeneration in the adult nervous system and will significantly enhance our understanding of how to elicit
regeneration and restore function to damaged neurons.

Public health relevance
Many axons do not regenerate and reform functional synapses with their target cells after nerve injury, a process called functional axon regeneration, often resulting in permanent deficits. The mechanisms that determine whether an injured axon will functionally regenerate are poorly understood. By determining how recently identified enhancers of functional axon regeneration regulate repair of the injured nervous system, this proposal will add significantly to our understanding of how an adult axon regulates its response to injury, which is critical for designing effective strategies to repair the injured nervous system.